Spatial metabolomics with subcellular resolution to identify therapeutic targets

Abstract
Cell death is a crucial physiological process. The resistance of cancer cells to therapeutic drugs is a significant
barrier to successful cancer treatment and the primary factor in cancer recurrence. Activation of novel cell death
pathways would resensitize drug-resistant cells to chemotherapy. Ferroptosis is a nonapoptotic cell death
activated when the lipid in the cell undergoes iron-dependent peroxidation. Our overarching goal is to investigate
lipid metabolism-driven cell death through the modulation of ferroptosis in cell culture and in vivo models of drug-
resistant cancer. The results will provide fundamental insights into the molecular chemistry of ferroptosis and its
role in disease pathology by developing a multi-omics approach with single-cell resolution. Diseases like cancer,
sepsis, pre-eclampsia, diabetes, cardiovascular disease, and neurodegenerative illnesses correlate with lipids
and lipid metabolism dysregulation. Lipid distributions are heterogeneous, and their chemical modifications, such
as lipid peroxidation, are potentially crucial for disease onset and progression. However, the precise relationship
between lipid distribution and their chemical modification and disease pathology is not fully understood. This
project investigates changes in lipid distribution and lipid peroxidation both in vitro and in tissues to provide
fundamental insights into their molecular chemistry and its role in disease pathology by using the experimental
methods developed in our group based on spatial chemical imaging. Our approach uses Raman imaging to
provide spatial information about lipids in the defined cellular compartments in contrast to the bulk or fractionated
examinations of extracted lipids provided by liquid chromatography-mass spectrometry (LC-MS). This proposal
builds upon our prior success in performing spatial imaging of lipid distribution in cells and tissues. The
hypotheses underlying this effort are that (a) there are significant heterogeneities in lipid distributions and their
chemical modifications, and (b) these heterogeneities can be correlated to the pathology of the disease. In
particular, we will: 1) Investigate the effect of ferroptosis on the lipid metabolism and iron metabolism of drug-
resistant cell lines in 2D culture; 2) Perform spatial mapping and profiling of lipids during ferroptosis in 3D cell
culture; 3) Detect ferroptosis and identify its associated mechanism in vivo. The project outcomes will improve
our understanding of the molecular mechanism, disease phenotype, and disease progression leading to better
therapeutic strategies.

Public health relevance
Project Narrative The resistance of cancer cells to therapeutic drugs is a significant barrier to successful cancer treatment and the primary factor in cancer recurrence. The proposed study investigates lipid-driven cell death in drug- resistant cancer by manipulating ferroptosis, an alternate cell death mechanism, utilizing the spatial lipidomics technique. 1